Professional Development (PD) Core

The Louisville Clinical and Translational Research Center (LCTRC) Professional Development (PD) Core shall
promote a diversity of training experiences to build a knowledgeable and thriving collaborative cross-disciplinary
community of Clinical and Translational Researchers at the University of Louisville (UofL). The PD Core aims to
address a lack of critical mass of investigators proficient in the core competencies required to create and translate
our innovations successfully. Through coordination with the Health Research (HR), Community Engagement and
Outreach (CEO), and Research Design, Compliance and Data Management
(RDCD) Cores, and with oversight from the Administrative Core (AC), the PD Core will build an innovative
educational program and mentoring program with the following aims:
Specific Aim 1: Develop a core of well-trained and supported early-stage clinician-investigators capable
of securing grant funding to sustain UofL's commitment to research and translation to practice.
Specific Aim 2: Build interdisciplinary teams and networks of investigators to promote innovation in C&T
Research.
Specific Aim 3: Nurture our pipeline of clinician scientists by developing C&T research skills and
competencies in our clinical professional students.
Specific Aim 4: Train clinical research coordinators and research nurses in best practices and policies
and mentoring practices to better support UofL’s clinical research enterprise. We will train and retain a
clinical research coordinator workforce to support anticipated increases in C&T research, provide 24/7 coverage
for acute care studies, and support community-engaged research in the LTCRC. Regular interactions with the
CEO Core shall promote and facilitate engagement in research by diverse members of the local community.
Impact. Success will lead to a sustained base of well-trained clinician-scientists and mentors representing the
diverse backgrounds of our target communities in South/West Louisville and Owensboro as they conduct
investigator-initiated C&T research in interdisciplinary teams in our LTCRC and improved healthcare outcomes
for the communities within Kentucky and beyond.